Support for University Biomedical Excellence at UPR-RP

DESCRIPTION (provided by applicant): The Rio Piedras RISE Program is requesting funding to continue to provide its twenty-five (25) undergraduate and thirty (30) doctoral research assistants with excellent opportunities to carry out research and to participate in program activities aimed at their professional development. Since RISE is a research-intensive program, all students will be expected to present their research results at national meetings and doctoral students will be expected to publish their results in international journals. Undergraduates will also participate in summer research internships at external sites and funds will be provided to those doctoral students who desire to carry out special experiments at other universities. The RISE Program will continue to provide seminars, technical workshops and special courses directed toward strengthening and enhancing the research capabilities of all its students. In this respect it will seek to assure that, as in the past, the large majority (>80%) of the undergraduate students successfully pursue doctoral studies in outstanding research universities. At the graduate level the program will not only seek to assure that, as in the past, the large majority (>70%) of doctoral students continue post-doctoral research experiences in prestigious laboratories, but that they complete their Ph.D. degrees in a timely manner.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Rio Piedras Campus is requesting funds for the competitive renewal of its RISE program and this include 25 students and 30 doctoral students. The program will continue to develop and improve activities in a manner that will allow it to assure that 80% of the undergraduates enter research doctorates and 70% of the doctoral students continue postdoctoral experiences. It will also assure that all of these students receive the necessary preparation to compete as effective researchers.